IGF::OT::IGF NExT Preclinical Toxicology & Pharmacology of Drugs Developed for Cancer Patients, TO#3, Exploratory Studies of CCR4 CART Cells

The test agent is being considered for development as an anticancer therapeutic. The objective of this task was to characterize the target organ toxicities of an investigative agent that might move forward to clinical testing for anticancer activity. The objective of this task was to obtain a source of tissue or cells for in vitro evaluations of toxicity. The information obtained from this investigation was used to identify drugs with the potential to treat cancer.